Visual Cortical Plasticity and the Implications for Sight Restoration Technologies

Project Summary
While only limited treatment options for diseases such as age related macular degeneration, glaucoma and retinitis
pigmentosa currently exist, there are variety of technologies being developed that attempt to restore some visual functioning,
including electronic prostheses (either cortical or retinal), optogenetics, and gene therapy. These technologies are not likely
to recreate normal vision, but rather provide essential visual input that can improve everyday functioning in patients.
In the current state of sight restoration technology, electronic and optogenetic sight recovery technologies cause early
on- and off-center retinal cells to fire simultaneously, rather than in a biologically complementary fashion (i.e. when on-
cells fire, off-cells representing the same location are suppressed). This creates deeply unnatural population responses that
propagate from the retina to cortex. The central question of this proposal is whether patients have the potential to access
cortical plasticity in adulthood that improves their ability to decode the unnatural cell population responses in early visual
processing elicited by electronic prosthesis or optogenetic technologies.
Here, we propose a unique way to understand the role of cortical plasticity in adulthood by examining whether normally
sighted individuals can learn to decode visually distorted images by playing action video games. We will manipulate the
spatial frequency, orientation and contrast information presented dichoptically to each eye in a way that provides a similar
decoding challenge to that posed by electronic or optogenetic prostheses.
This distorted information will be used in real time in a video game training paradigm, and we will then use an object
discrimination task as a test of perceptual learning. We will examine transfer of learning (for example, using monocular
stimuli, and switching filter eye of origin) to uncover specific mechanisms of learning (Aim 1). Next, using functional
magnetic resonance imaging, we will examine whether participants are learning to create novel neural representations of
objects during perceptual learning or whether there is a convergence with previous existing object representations in object-
selective brain areas (Aim 2). Finally, we will test whether perceptual learning is enhanced by short periods of binocular
deprivation (Specific Aim 3).
This work, examining the mechanisms underlying improvements in the ability to decode these distorted stimuli, will
provide developers of sight recovery technologies with empirical data about the potential of human participants to learn to
decode unnatural neural population responses in adulthood.

Public health relevance
Project Narrative Patients with loss of vision are likely to have a variety of sight recovery options available to them within the next ten years, but the vision provided by many of these novel technologies will be vastly different from that provided by normal vision. Our goal is to see whether it is possible to learn to adjust to this distorted vision in adulthood. Collectively these studies will have important translational implications for future sight recovery technologies, by revealing whether humans can learn to decode unnatural visual neural population responses in adulthood.